The effect of therapeutics on mutated IDH1 cell lines and mice tumor models

Using the methods described above, we have identified 2 IDH-mutated cell lines that are producing the expected phenotype and will be used for further investigations. The cells behave as expected in terms of D-2HG production and the response to different therapeutics will be determined in the future. We are evaluating different metabolic drugs as well as diets. The goal is to establish a combination of drugs or drug/diets that causes cellular death. once we understand the mechanism of cell death, we plan to test these in animal models.